Acquisition of a calScreener Isothermal Microcalorimetry System for Translational Cancer Metabolism Research at Roswell Park

PROJECT SUMMARY / ABSTRACT
Funds are requested to obtain a calScreener Isothermal Microcalorimetry System from Symcel at Roswell Park
Comprehensive Cancer Center. This instrument is a label free, cell-based assay system based on measuring
the heat flux/metabolism from living cells in real time and will provide unique value to investigators at Roswell
Park, and the surrounding area in Western New York. This system is cost effective, and can be used for
mammalian cells, bacteria, fungi, and parasites, in conventional cell culture, three-dimensional cultures, as well
as tissue samples. It functions independent of media composition, making it applicable to many different types
of projects. While there are tools for studying metabolism at Roswell Park (such as the Agilent Seahorse XFe96
Analyzer), there is no comparable technology to the calScreener. In fact, there are no comparable technologies
available anywhere on the market, and the nearest calScreener is in Milwaukee, WI, over 600 miles away.
Without this device, it would not be possible to investigate several important problems in cancer biology and
immunology. For example, traditional metabolism technologies, cells must be isolated and evaluated at specific
timepoints during an experiment. This instrument allows for continuous datacollection throughout an experiment,
allowing for the quantification of metabolism over time. It also allows for the analysis of entire tissue sections
without disrupting the architecture of the tissue. This allows investigators to study the effect of various treatments
on the metabolic state of the tumor microenvironment including chemo-radiation therapy, immunotherapy, and
metabolic inhibitors. Using these advantages, we can investigate the effects of inhibiting various metabolic
pathways in T cells, myeloid cells, and tumor cells as described in our research projects. Additionally, while most
researchers view heat production as merely an inert byproduct of metabolism, temperature flux is a major
component of the function of cells that we can now study. Thus, this instrument will allow us to answer
fundamental questions at the intersection of tumor biology, immunology, and thermobiology. The calScreener
will be housed in the Immune Analysis Facility (IAF), where it will be closely supervised and available as a shared
resource. There are 10 major users of the instrument that together will use ~80% of the instrument capacity. The
remaining instrument capacity will be made available to internal or external researchers through our on -line
scheduling and booking system. The IAF will generate a business plan, with a multidisciplinary advisory board
responsible for instrument oversight, while the Cancer Center will support the instrument through service
contracts, personnel, and marketing/promoting. Finally, this new instrument will not only provide unique data that
will enable researchers to best advance their programs to obtain new grants and publications, but it will also
provide a new dimension in pre-clinical and clinical applications that benefit cancer patients.

Public health relevance
PROJECT NARRATIVE Funding is requested for the shared used of the Symcel calScreener Isothermal Microcalorimetry System, a label-free cell-based assay system that measures the heat produced by living cells over prolonged periods of time. This instrument will bring a completely new technology and dimension of research to NIH funded investigators at Roswell Park Comprehensive Cancer Center, their collaborators around the world, and other researchers in the Western-New York area. Heat production is a fundamental property of living cells, and the remarkable ability to acquire real time data on heat production (and therefore the metabolic status of the cells) in complex cultures or whole tissue experiments will provide researchers with the capability of asking questions about cancer related cells/tissues that were previously not possible.